Etiology and Prevention of Oral Cancer

DESCRIPTION (provided by applicant): A model of progression of head and neck sqiamous cell carcinoma (HNSCC) in humans has been described which includes up-regulation of cyclin D1, activation of Stat-3, and expression of high levels of cyclooxygenase-2 (COX-2). Mutations and inactivation of p53 and other tumor suppressor genes (e.g. Rb, p16) have also been observed. Primary prevention, e.g., cessation of tobacco use, moderation of alcohol consumption, and increased intake of fruits and vegetables appears unattainable for a significant fraction of the population. Thus, other approaches such as chemoprevention are being explored. We have reported that selenium, as 1,4-phenylenebis(methylene)selenocyanate (p-XSC), inhibited tongue tumors of rats treated with 4-nitroquinoline-N-oxide (NQO). p-XSC also leads to growth inhibition and/or apoptosis in cultured human oral carcinoma cells, inhibits the formation of benzo[a]pyrene (B[a]P)-DNA adducts in the mouse tongue, and therefore has the potential of inhibiting B[a]P-induced tongue tumorigenesis. Based on these previous studies we hypothesize thatp-XSC inhibits tumorigenesis by multiple mechanisms including inhibition of DNA damage and cell proliferation, as well as induction of apoptosis in premalignant and transformed cells. To test our hypothesis we propose the following specific aims, Aim 1: To elucidate the mechanism of inhibition of NQO-induced tongue tumorigenesis by p-XSC. During tumor induction we will determine the effect of-XSC on: a) NQO-induced DNA damage; b) NQO-induced mutagenesis in vivo (in the lacI rat); c) NQO-induced (i) cell proliferation, (ii) apoptosis and (iii) proteins involved in cell cycle, cell proliferation, and apoptosis that have been implicated in the development of HNSCC (cyclin D1, Stat-3, COX-2, p16, pRb and p53). Changes in global gene expression will also be examined using eDNA microarray analysis; Aim 2: To determine the effect of p-XSC on tongue tumor induction by B[a]P in mice and on endpoints described in Aim 1; and Aim 3: To determine the effect of NQO or B[a]P, and p-XSC individually and in combination on certain of the biochemical, molecular and cellular events described in Aim 1 using cultures of normal cells, leukoplakia, and squamous cell carcinoma. To our knowledge, this application is the first to determine whether a tobacco smoke carcinogen (B[a]P) which induces tongue tumors in the mouse, alters those genes that are known to be involved in HNSCC and thus provides important leads toward the etiology of oral cancer. The long-term applications of this project may lead to strategies for the prevention and control of HNSCC. By identifying critical intervention targets in tongue tumorigenesis, it should be possible to minimize the gap between basic research and clinical application, and lead to translational clinical interventions.